PFAS exposure is detrimental to placental function and fetal development by disrupting mitochondrial function and metabolism

Per- and poly-fluoroalkyl substances (PFAS) exposure is widespread and has sparked major concerns about
health impacts in highly contaminated communities. The Feng lab has made significant contributions to our
understanding of the reproductive toxicity of PFAS by studying PFAS mixtures that replicate PFAS levels in
highly contaminated drinking water, as well as emerging PFAS compounds such as perfluorobutane sulfonic
acid (PFBS). We have reported that maternal exposure to PFAS mixtures and PFBS at environmentally relevant
doses leads to adverse birth outcomes through dysregulation of placental function and fetal neurodevelopment.
Recently, our preliminary data demonstrated that exposure to a PFAS mixture or PFBS leads to oxygen
accumulation in placentas and embryos during pregnancy and induces mitochondrial oxidative stress in both
human placental trophoblast stem cells and murine fetal brains. In this proposal, we will thoroughly examine our
hypothesis that PFAS exposure is detrimental to placental function and fetal development via disruption of
mitochondrial activities and metabolism. Our specific aims are to: 1) Investigate mitochondrial perturbations
associated with PFBS exposures in human placental trophoblast cells; 2) Determine which specific mitochondria-
relevant syncytiotrophoblast functions are altered by PFBS exposure; and 3) Assess alterations in placental
hemodynamics, oxygenation, and mitochondria-relevant metabolism by PFBS and PFAS mixtures in mice.
Novelty: We will address the health impacts of PFAS mixtures that mimic highly contaminated community
drinking water and specifically focus on an emerging PFAS compound, whereas most previous studies focused
on single legacy compounds and used less clinically applicable exposure levels. In addition, unique, optimized,
physiologically relevant human placental trophoblast stem cell-derived organoid models will be used to model
the human maternal-fetal interface in vitro. Finally, an innovative, in vivo photoacoustic imaging system will be
used to study placental hemodynamics in a mouse model longitudinally. This study will uncover potential
druggable intervention targets (mitochondrial oxidative stress) that might mitigate the adverse effects of perinatal
PFAS exposure. Furthermore, this study will advance our understanding of gender-specific health effects of
perinatal PFAS exposure that will undoubtedly have implications for personalized diagnostics and therapeutic
interventions. Feasibility: Combining expertise and preliminary studies provides a strong foundation for this
proposal. Dr. Feng’s lab has established the perinatal PFAS exposure in vitro and in vivo models; this proposal
is an extension of her previous projects. Dr. Schust's lab has extensive experience working with placental
trophoblast-derived organoids and developed the novel properly polarized system used here. Dr. Yao’s lab has
focused on developing novel photoacoustic technologies for assessing tissue hemodynamic parameters. Dr.
Santos is an environmental toxicologist focusing on mitochondrial toxicants. Our study will significantly contribute
to our understanding of the health impacts of PFAS and provide clues for intervention strategies.

Public health relevance
Public Health Relevance: Many communities near military and industrial sites have drinking water with high PFAS concentrations, yet the potential health risks associated with these exposures and emerging PFAS are not well understood. This study will contribute to the understanding of the impact of perinatal PFAS exposure on placental function and fetal development. Study findings will not only help address community concerns at Pittsboro, NC where drinking water was heavily contaminated with PFAS, but they will have widespread implications on our ability to understand the potential effects of elevated PFAS levels on health, inform policy, and identify clinical intervention targets.